Infection and prevalence of a new segmented flavivirus in the United States

Summary/abstract
Segmented RNA viruses that share phylogenetic relatedness with the prototypic Flaviviruses in their helicase
(NS3) and polymerase (NS5) proteins were recently identified from ticks, mosquitoes, and vertebrates, including
humans suffering with febrile illness. The first Flavi-like segmented viruses (FLSV) were isolated from ticks and
animals in the Jingmen province of China and were thus named Jingmen Tick Virus. Subsequently, highly diverse
FLSV variants were found in Africa, Europe and South America. However, no evidence of FLSV infection has
been reported in North America, including the United States. Moreover, several recent studies that used
metagenomics-based identification of the virome in ticks failed to identify FLSV infection. We were characterizing
the virome of free-ranging mice of the genus Peromyscus, the most common wild mouse species of the North
America, when we identified a highly diverse FLSV in several deer mice from woodlands in Pennsylvania (FLSV-
PN). We acquired partial sequences of all five segments of the FLSV-PN genome and developed serological
assays using Luciferase immunoprecipitation systems. Our serological data suggest that FLSV-PN or its related
variants have a wide host range and infect several economically important farm and domestic animals. Most
importantly, we found strong evidence of FLSV-PN infection in humans with a history of tick-bites and Lyme
disease. The long-term goal of our exploratory/developmental proposal is to define the pathogenesis and health
relevance of FLSV-PN infection. Development of molecular reagents for this new virus will allow us to test our
hypotheses that several genetically diverse FLSV variants are circulating in the United States, and these viruses
are predominantly transmitted by ticks to humans and animals. Specific aim-1 is to acquire the complete
genomes of several diverse FLSV variants. Our preliminary data suggest that FLSV-PN genome is comprised
of five RNA segments that are polyadenylated at the 3’ end. Complete genome sequencing of FLSV-PN is
necessary for the development of sensitive and specific diagnostic assays to study infection prevalence and
disease associations. Specific aim-2 is to determine the infection prevalence of FLSV in humans, domesticated
animals and ticks. These studies will be aided by samples and data available from clinical research studies of
Lyme disease at NIAID, NIH (letter of support attached). The proposed aims represent crucial steps toward
detailed molecular and biological characterization of FLSV-PN, including the development of a reverse genetics
system, replicon systems, cell culture and animal models. Although the health relevance of FLSV infections is
currently not known, the proposed studies will inform this knowledge as well as develop the reagents for
preventing the spread of this new virus and associated diseases, if necessary.

Public health relevance
Public health relevance/ Narrative Early prevention of new viral infections and spread requires development of specific and sensitive diagnostic assays. We found evidence of a new Flavi-like segmented virus (FLSV-PN) infection in several economically important farm and domestic animals as well as in humans with a history of Lyme disease. We will generate genetic data of FLSV-PV variants circulating in the United States and develop new molecular assays to study FLSV-PN infection and identify potential disease associations.